Component A: BD-STEPS Core at the NC Center for Birth Defects Research and Prevention

Project Abstract
Component A: BD-STEPS Core at the NC Center for Birth Defects Research and Prevention
Birth defects are a leading cause of infant mortality and childhood morbidity, yet the etiology of most cases is
unknown. Established in 2002 with funding from the CDC, the North Carolina Center for Birth Defects
Research and Prevention (NCCBDRP) has been a major contributor to the National Birth Defects Prevention
Study (NBDPS) and Birth Defects Study To Evaluate Pregnancy exposureS (BD-STEPS). The next phase of
BD-STEPS will continue to build on these important multi-site, population-based case-control studies to identify
novel epidemiologic and genetic risk factors for major structural birth defects that can be translated into
prevention strategies. The NCCBDRP's Specific Aims are to (1) Implement the BD-STEPS Core protocol in
North Carolina including: (a) Utilize the existing state-wide, population-based birth defects surveillance system
in NC to actively ascertain at least 150 cases per year among livebirths, stillbirths and elective abortions with a
study-eligible birth defect in the demographically diverse 33-county study area; (b) Utilize birth certificates to
identify an eligible population-based sample of approximately 100 control infants per year born in the same
study area; (c) Conduct clinical case review and classification by clinical geneticist and pediatric cardiologist
using abstracted medical records; (d) Partner with CDC's central interviewing contractor to facilitate NC
participation in the core interview and online occupational survey; (e) Conduct supplemental data collection
about reportable infections before and during pregnancy; (f) Conduct supplemental biospecimen collection of
residual newborn blood spots; (2) Establish a unique data resource for investigating prescription medication
use during pregnancy and birth defects by linking BD-STEPS and NBDPS participants in NC with health
insurance claims records from NC Medicaid and Blue Cross Blue Shield NC; (3) Establish a unique
biospecimen resource for investigating prenatal environmental exposures and birth defects by collecting shed
deciduous teeth from BD-STEPS and NBDPS participants in NC; (4) Leverage the NCCBDRP's well-
established group of investigators and collaborators to develop innovative, high-impact studies with BD-STEPS
and NBDPS data on genetics, epigenetics, and gene-exposure interactions associated with birth defects, and
epidemiologic risk factors for birth defects including medication use during pregnancy, maternal chronic and
infectious disease, and key social determinants of health such as individual- and neighborhood-level
socioeconomic factors, acculturation, employment and workplace conditions, and environmental factors; (5)
Produce at least seven NC-led manuscripts for publication in high-impact journals using pooled data from BD-
STEPS and/or NBDPS during the 3.5-year award period; and (6) Continue our long-standing, successful
training program in birth defects epidemiology.

Public health relevance
Project Narrative Component A: BD-STEPS Core at the NC Center for Birth Defects Research and Prevention Birth defects affect approximately three percent of all births yet account for 20 percent of infant deaths and contribute substantially to childhood morbidity and long-term disability. The North Carolina Center for Birth Defects Research and Prevention (NCCBDRP) is a long-standing partnership between the Department of Epidemiology at the University of North Carolina at Chapel Hill, and the North Carolina Birth Defects Monitoring Program at the North Carolina Division of Public Health. The NCCBDRP will implement the multi-site, population-based Birth Defects Study To Evaluate Pregnancy exposureS (BD-STEPS) in a demographically diverse 33-county area of North Carolina to identify novel epidemiologic and genetic risk factors for major structural birth defects and to advance public health strategies for birth defects prevention.